Mitochondrial-epigenetic crosstalk in regulation of airway hyperresponsiveness

Project Summary
Asthma is a complex disease characterized by airway hyperresponsiveness (AHR), which is expected to affect
400 million people worldwide by 2025. Airway smooth muscle (ASM) cells are the primary effectors of AHR, as
they exaggerate the response to bronchoconstrictor stimuli and increase ASM thickness by depositing the
extracellular matrix and inducing inflammation. Targeting epigenetic changes serves as a new approach to
reversing the aberrant ASM phenotypes seen in asthmatics. We previously demonstrated that global DNA
hydroxymethylation mediated by α-ketoglutarate (αKG)-dependent 5-mC dioxygenase (TET1) was induced in
lung tissues from mice that showed increased allergen-induced AHR. In addition, we reported a novel role for
mitochondrial-specific isocitrate dehydrogenase 2 (IDH2) on regulation of ASM phenotypic genes in human
asthmatic ASM cells, through alterations in αKG level and αKG-dependent TET1 activity, suggesting a possible
link between cell metabolism and epigenetic regulation of ASM cell function. Preliminarily, the allergen-
induced AHR and aberrant DNA hydroxymethylation patterns was abolished by a mitochondrially targeted
tetrapeptide, SS-31(elamipretide, which is currently in phase III clinical trials for treating metabolic diseases).
Furthermore, we showed that the interaction between mitochondria and epigenome is bidirectional. We
identified increased DNA hydroxymethylation of genes involved in mitochondrial replication and transcription,
which was associated with the increased AHR. Our study represents the first demonstration that TET1-
mediated DNA hydroxymethylation in ASM is regulated in the context of mitochondrial function, although the
mechanisms by which mitochondrial function influences the epigenetic regulation of ASM cell function, and
vice versa; have not been fully investigated. Based on these novel findings, we propose the central hypothesis
“Modulation of mitochondrial redox cycling and bioenergetics reciprocates with the epigenetic modifications of
the ASM cell function, and ultimately modifying asthma pathogenesis”. To address these novel hypotheses, we
assemble a team of investigators with a breadth of expertise spanning the fields of epigenetics, redox biology
and pulmonology. First, we will determine whether modulation of mitochondrial function has an epigenetic
impact on allergen-induced AHR, which can be attenuated by SS-31. Second, we will study if epigenetic
regulation of mitochondrial transcription modulates mitochondrial function, which has a long-term effect on the
epigenome of the ASM cells and AHR phenotype. Finally, we will confirm the mitochondrial-epigenetic
interplays in the determination of ASM function utilizing clinical samples. We will apply correlation analysis of
genomic profiling and measurement of mitochondrial biology to identify sets of molecular markers associated
with asthma severity. Our findings should provide new evidence about the mitochondrial-epigenetic crosstalk in
ASM cells and the results of that interaction on AHR. These insights may fuel the development of new
therapeutic approaches for the treatment of this debilitating disease.

Public health relevance
Project Narrative To date, the etiology of asthma remains unclear and existing therapies do not fully cure asthma, prompting us to explore the underlying mechanisms in asthma pathogenesis in order to find novel treatment for asthma. Previous studies from our groups demonstrated a possible link between cell metabolism and epigenetic regulation of airway smooth muscle cell function. Given the reversible nature of epigenetics, we propose to further our understanding on the epigenetic modifications preventing asthma or alleviating asthma exacerbation by investigating the impact of mitochondrial-epigenetic crosstalk on allergen-induced airway hyperresponsiveness.